Technology Core

Project Summary, Technology Core:
This innovative integrated systems biology application seeks to delineate the complex host/pathogen interactions
occurring at the alveolar level that lead to unsuccessful response to therapy in severe pneumonia. The overall
goal of the Technology Core is to provide sample processing and data generation support for all projects and
other cores in the Successful Clinical Response In Pneumonia Therapy (SCRIPT) Systems Biology Center. Our
Technology Core is uniquely poised to contribute to the success of the SCRIPT Study, as we possess expertise
in flow cytometry, cell sorting, various Next Generation Sequencing techniques, including RNA-seq for gene
expression profiling and genome-wide bisulfite sequencing for genomic DNA methylation, and humanized mouse
modeling. The Technology Core will process clinical samples, isolate specific cellular populations and perform
their transcriptional and epigenetic profiling for Project 1 and the Data Management and Bioinformatics Core,
and generate humanized MISTRG mice and perform transcriptional profiling of alveolar macrophages from these
mice for Project 2 and the Modeling Core.
Aim 1: To isolate and immunophenotype subsets of macrophages/monocytes and T cells from non-
bronchoscopic bronchoalveolar lavage (NBBAL) and peripheral blood patients with pneumonia via fluorescence-
activated cell sorting (FACS).
Aim 2: To perform transcriptional and epigenetic profiling of macrophage and T cell subsets isolated from NBBAL
from patients with pneumonia.
Aim 3: To validate pathogen-specific gene expression signatures observed in patients with pneumonia using a
humanized MISTRG mouse model.

Public health relevance
Project Narrative It is not required per instructions stated on the Funding Opportunity Announcement RFA-AI-16-080, Section IV. Application and Submission Information, Technology Core, Research & Related Other Project Information (Technology Core), “Project Narrative: Do not complete”.